Phage-Bacteria Evolution via Next-Generation Phage Bioreactors

Project Summary/Abstract
Multi-drug resistance to conventional antibiotics is precipitating a medical crisis. An estimated 3
trillion in costs and excess loss of 10 million lives is expected by 2050. The chemical antibiotic
pipeline has run dry, disincentivized by the rapid development of resistance and lack of financial
gain after product development. Phage therapy has emerged as a viable treatment alternative,
where bacteriophage (phage for short), which are viruses that only infect bacteria, are used as
naturally adaptive drugs to treat infections that no longer respond to currently available
antibiotics. However, bacteria also mutate to resist phage infections, which limits treatment.
Unlike antibiotics, phage can counter-adapt to these bacterial mutations, thereby killing so-
called “resistors.” This raises the possibility of developing phage cocktails populated with phage
that “anticipate” the resistance trajectories of bacteria and thus limit or prevent resistance
altogether. For this purpose, we have developed a co-culture system that maintains continuous
logarithmic bacterial growth so as to maximize phage production on a permissive bacterial host,
thereby facilitating the emergence of rare phage variants that “train” to kill target resistors in a
secondary vessel. Hypothesizing that this system will allow us to chart all resistor mutations for
a given bacterial species and counter-adaptations by phage, the aims of this work are to
optimize the growth parameters to maximize novel evolutionary adaptations for both agents. In
Aim 1, we study the effect of nutritional status, aeration, temperature, and the bacterial/viral
propagation strains in driving lineages of adaptation, both in the presence and absence of
chemical and genetic mutators. For Aim 2, we sequence all lineages that emerge every 6 hours
for 7 weeks (~ one evolutionary cycle) to chart the mutations for bacteria-phage interactions to
identify how resistance undermines phage therapy and phages that will contribute to anti-
resistor cocktails. With this knowledge, we can develop phage cocktails that block common
avenues for bacteria to escape phage treatment.

Public health relevance
The purpose of this project is to understand the evolutionary dynamics between phage and bacteria as they undergo adaptation and counteradaptation to live/die pressures. By determining the mutations that drive bacterial resistance or phage killing, it will inform clinical practice through the selection of phage for cocktails that anticipate and thus prevent resistance (and improve therapeutic outcomes).